Circadian and Ultradian Cortisol Rhythms in Chronic Sleep Continuity Disturbance

ABSTRACT
Approximately 30-50% of the US population experiences acute sleep continuity disturbance (i.e., insomnia) per
annum, and approximately 10% of the population report chronic levels of insomnia. Chronic insomnia (CI) is
associated with significant daytime impairment and is a substantial risk factor for multiple psychiatric and
medical disorders. Given CI's prevalence and consequences, it is essential to identify factors that perpetuate
this disorder. One of the leading candidates for the neurobiological basis of CI is hypothalamic-pituitary-adrenal
(HPA) axis dysregulation, specifically, alterations in cortisolinergic tone. Cortisol secretory patterns exhibit both
a circadian and an ultradian rhythm. Ultradian pulses (i.e., every 60-120 minutes) are hypothesized to be
involved in the maintenance of wakefulness during the day and may be related to the inhibition of wakefulness
at night (i.e., the inhibition of pulses promotes the consolidation of sleep). While cortisol pulses naturally occur
with transient awakenings, we hypothesize that these pulses can become a conditioned phenomenon in CI that
predisposes the individual to awaken and/or experience prolonged nocturnal awakenings. Increased cortisol
pulses during the day may also be expected because of the increased effort required to maintain wakefulness,
and in turn, these increased pulses may further condition the aberrant occurrence of cortisol pulses at night.
The scientific aims are (1) to evaluate whether subjects with CI, as compared to good sleepers, exhibit greater
ultradian cortisol pulsatility during the day and/or at night, and (2) to quantify the association between ultradian
cortisol secretion and metrics related to spontaneous awakenings from sleep (i.e., timing, frequency, duration,
and EEG spectral profile of the awakenings). The proposed study will be conducted as a between-subjects
design, examining 20 individuals with CI and 20 good sleepers during two consecutive nights in the laboratory
(Night 1 is a screening night). While in the lab, blood will be sampled every 10 minutes for 24 hours and sleep
will be polysomographically recorded. A refined delineation of both the circadian and ultradian aspects of
cortisol secretion may allow for a better understanding of the etiology of chronic insomnia, the efficacy of
established treatments, and potentially the development of new therapeutic approaches. The training plan
includes educational activities that encompass three broad topic areas: (1) general skills (i.e., professional,
ethics, and research training activities), (2) principles and practice and methodology issues related to
neuroendocrinology, and (3) principles and practice and methodology issues related to behavioral sleep
medicine and sleep medicine. The training plan builds upon the applicant's background in depression-related
sleep research and stress physiology and provides the necessary training in neuroendocrinology, behavioral
sleep medicine, and sleep medicine to further explore and document any association of HPA-axis
abnormalities with persistent wakefulness at night. The pedagogic approach includes routine one-on-one
mentorship, directed readings, course work, mini-fellowships, lab-based trainings, and conferences/workshops.

Public health relevance
PROJECT NARRATIVE The aim of the present proposal is two-fold: (1) to foster the candidate's development as an independent investigator and (2) is to explicitly assess the circadian and ultradian secretory patterns of cortisol in patients with insomnia as compared to good sleepers. With respect to the former, a Mentored Patient-Oriented Research Career Development (K23) Award will provide the candidate the flexibility and resources to become an emerging expert on the cross-section between neuroendocrinology and behavioral sleep medicine. With respect to the latter, the guiding hypothesis is that alterations within the ultradian domain are more related to the incidence and severity of insomnia than alterations in the circadian domain. Relevant findings may: 1) provide an alternative perspective on the etiology and pathophysiology of insomnia (i.e., from acute symptomatology to persistent sleep continuity disturbance) and 2) suggest alternative treatment strategies. !